Biology of the Hormonal Regulation of Cancer and Immuno Oncology Outcomes Research Proposal.

PROJECT SUMMARY / ABSTRACT
This application is being submitted in response to “Administrative supplements to advance development of
transdisciplinary and large-scale population science and cancer control research projects." Despite the
significant progress made in cancer treatment across a broad range of indications by immune checkpoint
blockade (ICB), a majority of patients still do not respond. The potential of these medications to improve cancer
outcomes is additionally limited by the frequency and severity of immune-related adverse events (irAEs), class-
specific toxicities of checkpoint inhibitors that can affect any organ system. Sex hormones, including both
estrogen and androgens, have recently been identified as both a contributor to resistance to checkpoint
inhibition and a risk factor for irAEs. The mechanisms by which this immunomodulation occurs, however, is not
yet understood. This proposal will develop a framework for a set of studies to test the hypothesis that
understanding hormone receptor expression and its impact on immune infiltration of the skin and
gastrointestinal tract will provide insight into mechanisms of both irAE pathogenesis and resistance to ICB. Our
team of transdisciplinary investigators comprises clinicians in multiple subspecialties as well as researchers
with population science, computational biology, immunology, and cancer expertise, which provides the diversity
of viewpoints necessary to build a framework supporting true bedside-to-bench-to-bedside translation. Using a
whole person approach-from cancer diagnosis to symptom biology to treatment-associated toxicities and tissue
specific hormone signaling, and finally the sex-specific immune landscape, we are integrating an array of
methods to synergistically address sex differences in ICB and irAEs. Toward this end, this proposal will
assemble a sex-balanced cohort of patients with cancers of the skin or gastrointestinal tract treated with
standard-of-care ICB at the Knight Cancer Center (an NCI-designated Comprehensive Cancer Center) who
have archived pre-treatment tissue blocks available. Treatment metadata on these patients will be integrated
with data on their clinical features, symptom biology, hormone receptor expression, and publicly-available
single-cell RNA sequencing data, creating a comprehensive treatment-, outcome-, symptom-, and tissue
biology-informed repository for the study of the interface between hormone biology and cancer immunotherapy.
This resource will then serve as the foundation upon we will build a comprehensive cancer control protocol for
future prospective studies. This protocol will allow us to fully leverage our existing (dermatologic and
gastrointestinal) toxicity care clinics within the Knight for recruitment of appropriate patients into both existing
and novel research pipelines, allowing us to derive maximum experimental benefit from every patient willing to
participate. Collectively, the efforts enabled by this proposal will drive a multi-armed research effort upon which
we plan to build a future larger-scale program project application.

Public health relevance
PROJECT NARRATIVE Despite advances in immune checkpoint blockade (ICB) for cancer treatment, most patients do not respond and may suffer from serious immune-related adverse events (irAEs), which limit therapeutic benefit. Emerging evidence suggests sex hormones influence both resistance to ICB and susceptibility to irAEs, yet the underlying mechanisms remain unclear. This supplement will develop methods to integrate whole person population science to elucidate sex differences in cancer treatment toxicities and outcomes which will guide the mechanistic investigation of sex hormones as regulators of inflammation in barrier tissue cancers.